Research Supplements to Promote Diversity in Health-Related Research

Abstract
Diversity on science teams has been shown to increase research productivity and creativity, yet
the scientific workforce lacks sufficient diversity. The long-term research career goal of the
applicant is to develop research interventions and tools that provide guidance on how to bring
diverse voices together in the research workplace. The overall objectives in this application
are to: 1) gain a clearer understanding of what diversity, equity, and inclusion is and what
contributes to it in the workplace through training, 2) design, implement, and test research
questions that assess perceptions of inclusivity among underrepresented postdoctoral fellows
and junior faculty in academia, 3) disseminate and translate research findings on inclusivity at
the institutional level. The rationale for this project is that identification of perceptions of
inclusivity among underrepresented individuals in the workforce is the first step to
understanding what does and does not work at the institutional level. The parent grant, Building
Up study, provides robust infrastructure and support for this work with the following specific
aims: 1) Conduct a cluster randomized controlled trial to test the CEED intervention; 2) Study
what factors impact participants; and 3) Disseminate the CEED intervention to other
institutions. The research proposed in this application is innovative because it assesses
perceptions of inclusivity among underrepresented postdoctoral fellows and junior faculty at 25
institutions that are almost all primarily white. During this assessment period, we have the
opportunity to assess if underrepresented postdoctoral fellows and junior faculty plan on leaving
their institutions and if so, why. This information is of great value because individuals from
underrepresented backgrounds are more likely to leave primarily white institutions or academia
altogether. The proposed research is significant because it assesses underrepresented
individuals’ perceptions of diversity, equity, and inclusion policies and procedures, as well as
their sense of belonging, autonomy, respect, and inclusion.

Public health relevance
Narrative The proposed supplemental research is relevant to diversifying the biomedical research workforce because it focuses on how diversity, equity, and inclusion efforts impact one’s sense of belonging in higher education. The ability of individuals from diverse backgrounds to work together has long-ranging implications on productivity and creativity. Inclusivity is the glue that keeps diversity in place at institutions and allows dynamic work to happen. Thus, the proposed research is relevant to the part of the NIH and NIGMS missions that pertain to increasing diversity in the research workforce and ensuring the vitality and productivity of the research enterprise. 1